Research Network on Decision Neuroscience and Aging

PROJECT SUMMARY / ABSTRACT
The overall goal of this grant is to continue supporting the multidisciplinary Scientific Research Network on
Decision Neuroscience and Aging. The integrative emerging area that this grant will support combines the
strengths of several fields including psychology, neuroscience/neurology, medicine and economics to facilitate
rapid scientific progress and directly contribute to the development of effective interventions and policies to
improve health and well being across the life span and reduce the burden of Alzheimer’s Disease and related
dementias (ADRD). After ten years of establishing this network, the next five years will be focused on
strengthening the link between basic research on decision making and aging and clinical research on decision
making and ADRD. This will involve growing the network participation to include emerging scientists interested
in ADRD as well as expanding our advisory board to include ADRD experts. Over five years this network grant
will support scientific meetings, intensive training workshops for researchers at all stages, collaboration and
mentorship initiatives, and pilot grant competitions for researchers new to the field. These activities will directly
support the growth, development, and sustainability of the decision neuroscience of aging. This grant will
support growth of the network through dissemination activities. Scientific meetings will increase awareness of
the latest findings with the goal of drawing new researchers into the area and encouraging new collaborations.
A small grant competition will encourage scientists to join the area and will stimulate new research through
small scale pilots. This network grant will support development of the area through methods workshops and an
outside mentorship program. Short, intensive workshops will focus on training researchers at all stages in the
collection and analysis of various emerging behavioral and biological measures and introduce investigators to
new research areas to expand the scope of their own work and build new collaboration opportunities (e.g.,
clinical ADRD science for decision making researchers; decision neuroscience for clinicians). The development
of these skills is currently difficult to achieve in traditional single discipline training programs, but will be
essential for taking advantage of the growing number of large multivariate and multi-level integrative datasets
generated by this type of research, especially prevalent in ADRD research. The network will focus on investing
in the sustainability of this field by ensuring that students, fellows, and faculty are invited to participate in all
activities. Workshops, meetings, small pilot grants, and collaboration initiatives will facilitate the transition from
the current growing group of individuals managing network activities to a strong field of researchers leading
future work in this area. After completion of activities, this emerging area will be in better position for network
members to pursue funding to support the network in the future using more traditional mechanisms.

Public health relevance
PROJECT NARRATIVE Relevance As the proportion of older adults in the population continues to expand, magnifying the relative impact of their decisions, it is increasingly imperative to better understand changes in decision making across the life span before and throughout all stages of significant cognitive impairment related to Alzheimers Disease and related dementias. Increasing interdisciplinary research combining psychology, neuroscience/neurology, medicine, and economics has tremendous potential for increasing translation of science for real-world impact to better understand and alleviate the burden of Alzheimers Disease and related dementias. The long-term goal of this network is to conduct integrative and multidisciplinary research that contributes directly to interventions aimed at improving health and well being in the daily lives of aging adults.